Sex-specific role of CCL5/CCR5 axis in depression and its therapeutic implication

Summary/Abstract
Major depressive disorder (MDD) is a widespread psychological disorder affecting ~7% population in the
U.S. The prevalence is even higher in veterans. It was estimated that approximately 30% of Operation
Enduring Freedom (OEF) and Operation Iraqi Freedom (OIF) veterans are affected by depression. Sexual
dimorphism in depression is well documented. Women and men differ in the prevalence, symptom
presentation, and responses to antidepressant treatment. However, the majority of scientific investigations
have been predominantly conducted in male models due to experimental limitations. Chronic social defeat
stress (CSDS) is one of the best-established models to study depression and has been largely limited to study
male depression. Recently, Dr. Russo's lab developed a female CSDS paradigm that consistently produced
depression-like behaviors in female mice and has since been adopted in our laboratory.
Induction of inflammatory cytokines in the periphery contributes to depression-like behaviors both in
humans and in experimental models. Previously, it was found that stress-induced peripheral IL-6 plays an
important role in determining stress-susceptibility in male mice. Characterization of peripheral inflammation in
female mice following CSDS revealed positive correlation between stress-susceptibility and plasma levels of C-
C motif chemokine ligand (CCL5), but not with IL-6. Higher level of CCL5 was also reported in human subjects
with MDD and higher levels of peripheral CCL5 in women compared to men, implicating sexual dimorphic
interactions between CCL5 expression and depression. Gene expression analysis revealed that CCL5 receptor
CCR5 was significantly higher in stress-susceptible female mice in the prefrontal cortex (PFC), a brain region
known to play important role in depression, and this increase was not seen in stress-susceptible male mice.
Cross-examination with human MDD RNA-seq data showed that in female MDD subjects, the level of CCR5 in
the ventromedial PFC was 2.8 fold higher compared to the control subjects and this increase was not seen in
male MDD subjects, suggesting conserved responses to stress in human and mouse.
CCR5 is a seven-transmembrane G protein-coupled receptor expressed in microglia, astrocytes and
neurons in diverse brain regions. Ligand activation of CCR5 has been show to suppress adenylyl cyclase,
activate PI3K/AKT and MAPK signaling and alter intracellular Ca2+ mobilization, all of which can influence
synaptic function. Based on these observations, we hypothesize that in female mice, defeat stress induces
peripheral increase of CCL5 and its interaction with CCR5 in the brain dysregulates synaptic plasticity and
promotes stress-susceptibility. We propose to modulate CCL5 in the periphery or manipulate the CCL5/CCR5
signaling, either pharmacologically or genetically in the PFC, and use a battery of neurobehavioral tests,
immunological and molecular techniques to test the role of CCL5 and CCR5 in stress-susceptibility in females,
and compare the responses to male mice. We will also investigate whether stress-induced neurovascular
damage and associated blood brain barrier leakage may facilitate peripheral CCL5 infiltration to the brain.
Lastly we will investigate whether oral application of a FDA approved CCR5 antagonist is effective in treating
mice with depression-like phenotype and to compare its efficacy with antidepressant fluoxetine.
We believe our approach will greatly enhance our understanding of the pathophysiology underlying
depression in female and fill the gap in current scientific knowledge on sex-specific periphery and central
mechanisms underlying depressive disorder. The treatment intervention proposed in the application will
provide immediate bench-to-bed translation and may significantly improve the health and lives of veterans
affected by the stress disorders including depression, anxiety disorders and posttraumatic stress disorders
(PTSD), particularly relevant to the health and wellbeing of female veterans.

Public health relevance
Narrative There is strong sexual dimorphism in the prevalence, symptom presentation and in response to antidepressant treatment in major depressive disorder (MDD). The proposed study will use a recently established female social defeat mouse model to investigate the role of CCL5 and CCR5 in the pathogenesis of depression and to repurpose maraviroc as a novel therapeutic for treating depression. A successful outcome of the application will fill the gap of knowledge in female social stress and provide experimental evidence and supporting data for targeting CCL5/CCR5 axis as novel antidepressant therapy.